Life-Cycle Health and Wealth in Transition Economies

[unreadable] DESCRIPTION (provided by applicant): This project will examine the relationship between socioeconomic status (SES) and health over the life-course in two 'transition' economies, China and Russia. While the SES-health relationship has become of increased interest across a variety of disciplines, the majority of this work has focused on the most developed nations. Further, most studies have focused only on establishing the empirical correlation, with less attention to the specific channels through which it arises, or even direction of causality. To address these gaps, this project contains 6 interrelated components: 1) document the SES-health relationship for China and Russia, including how the relationship has changed over time, and the role of various explanatory factors; 2) examine the relationship between nutrition, food choice and income, and the implications for health; 3) explore the health consequences of various 'psychosocial' factors, such as economic stress, inequality and rank; 4) examine the short- and long-term health effects of economic shocks, and the range of strategies used to cope with such shocks; 5) examine the long-run health and income effects of childhood economic shocks; 6) examine the distribution of resources within extended, multigenerational households, and the implications for health. [unreadable] [unreadable]